BENCHMARKING LTQ-ORBITRAP VELOS WITH OUR PIPELINE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. We were approached by Dirk Valkenborg in Belgium to help them benchmark their new instrument using our analysis pipeline. They have been trying to reproduce the work we reported in the Second et al, Anal Chem 2010 paper and without our tools it is hard to differentiate the cause of the differences. We are going to put the data through, BullsEye, SEQUEST, Percolator, and MSDaPL Protein Inference for them.